Short and long term outcomes of doxycycline versus TMP-SMX for SSTI treatment

Project Summary / Abstract
Community-associated (CA) skin and soft tissue infections (SSTIs) pose a substantial health burden
worldwide. SSTI incidence in the U.S. has increased 50% in the past decade resulting in over 10 million visits
to healthcare providers annually. This increase is driven by the emergence of community-associated
methicillin-resistant Staphylococcus aureus (MRSA) strains, which now cause the majority of SSTIs. No other
infectious disease has seen such a dramatic rise. Of great concern is that SSTIs are complicated by high rates
of recurrence (>50% in 1 year), as well as hospitalization, severe sepsis, and even death.
Current guidelines inadequately address the role of older, inexpensive antibiotics for SSTI treatment.
The disconnect between the high incidence of SSTIs, which exceed that of pneumonia and urinary tract
infections, and the lack of data to guide prescribing physicians is unjustifiable and can only be addressed by
high quality clinical trials. Recent studies have demonstrated that clindamycin and trimethoprim-
sulfamethoxazole (TMP-SMX) have similar efficacy and safety for uncomplicated SSTIs (uSSTIs). Both have
efficacy, when combined with incision and drainage, that exceeds that of placebo. However, clindamycin
resistance among S. aureus in the U.S. is increasing and exceeds 90% in some parts of the world. TMP-SMX
is also limited by higher rates of recurrent SSTIs compared to clindamycin and by emergence of TMP-SMX
resistance among S. aureus in populations where use of TMP-SMX is high.
Doxycycline is the natural choice for study of uSSTI treatment. Its tolerability, low cost, and promising
preliminary data for SSTI management suggest it is efficacious and safe for uSSTI treatment. Unfortunately,
high quality comparative effectiveness data for SSTI treatment with doxycycline are lacking.
We will perform a clinical trial of uSSTIs, targeting infections likely to be caused by CA-MRSA and
populations previously ignored in other trials of SSTIs (e.g., diabetics, obese persons). We will compare the
efficacy and safety of doxycycline versus TMP-SMX for the treatment of suppurative uSSTI in older children
and adults. We will also compare efficacy of preventing recurrent uSSTIs up to 12 months after initial treatment
and define the relationship between nasal and oropharyngeal colonization and treatment success and
recurrence. We will quantify and characterize emergent colonizing antibiotic-resistant S. aureus isolates.
Finally, we will develop a new clinical trial outcome for SSTIs using the Desirability Of Outcome Ranking
(DOOR) design for this trial. This outcome will complement our more traditional primary outcome by capturing
meaningful patient-centered outcomes. DOOR outcomes can reduce sample size of future SSTI clinical trials,
thus making future trials less expensive and more feasible. Our investigation will be critical in defining the role
of doxycycline for uSSTI treatment and lay the foundation for evidence-based therapies that improve short and
long term patient outcomes in this extremely common yet understudied infection.

Public health relevance
PROJECT NARRATIVE Despite the fact that community-associated skin and soft tissue infections (SSTIs) have an incidence that exceeds 10 million visits to healthcare providers annually and can results in hospitalization, severe sepsis, and even death, the comparative effectiveness of older generic, yet promising antibiotics remains unstudied. Doxycycline is highly promising for SSTI therapy given its tolerability, its low cost, and promising preliminary data and the need for high quality data and adequately powered studies are more important than ever given rises in clindamycin resistance among S. aureus and TMP-SMX’s association with high rates of relapse. We will compare the short term and long term efficacy and safety of doxycycline versus TMP-SMX for the treatment of suppurative uncomplicated SSTI as well as describe the role of nasal and oropharyngeal colonization and the emergence of colonizing antibiotic-resistant S. aureus isolates, which will be key to understanding the optimal therapies to improve short and long term patient outcomes in this extremely common yet understudied infection.